New reagents for C-C and C-N bond formation

PROJECT SUMMARY/ABSTRACT
Chemical synthesis has long benefited public health through the discovery and preparation of
pharmaceuticals, the synthesis and study of natural products, and the development of new methods for drug
delivery among many others. The continuation and acceleration of such contributions requires the
development of new chemical methods with a focus on increasing selectivity, efficiency, practicality and
scalability, and the ability to access diverse and novel chemical space. Our laboratory focuses on the creation
of new chemical methods, novel reagents, and the total synthesis of bioactive natural products. Each project
focuses on filling a key gap in the literature while delivering end products that will be of immediate and practical
use to the scientific community, both in the context of fundamental chemistry and translational drug discovery.
This proposal combines two distinct, but thematically linked, programs that share the overarching goal
of developing novel methods and reagents to enable new chemical transformations and explore new chemical
space with direct applications to medicinal chemistry, natural product synthesis, and drug discovery. The first
section of the proposed work will develop new methods that allow for the efficient installation of sulfonimidoyl
moieties onto both simple and complex scaffolds and the use of sulfonimidoyl-containing reagents for the
syntheses of otherwise difficult-to-access chemical space including pharmaceutically relevant spirocycles and
natural products. Among the methods in this proposal are the synthesis and applications of sulfoximines as
asymmetric molecular transfer reagents, the use of sulfoximines as chiral anion stabilizing groups for anion
relay chemistry, the development of modular syntheses of sulfonimidoyl fluorides and chiral bifunctional
sulfonimidoyl linchpin reagents. In the second section, diazirines are developed as unique nitrogen transfer
reagents, which react with a wide variety of chemical handles including carboxylic acids, unactivated C–H
bonds, alcohols, and α-positions. The products of these reactions, diaziridines, are versatile heterocycles that
are easily transformed in one step to high-value amines, hydrazines, and nitrogen-containing heterocycles.
This chemistry will be applied in the target-oriented synthesis of hydrazine, hydrazide, and piperazic acid-
containing natural products, asymmetric transformations, and the synthesis of novel probes for proteomics.
The chemistry developed throughout this proposal will enhance the discovery and development of new small
molecule therapeutics across disease states in both academic and industry.

Public health relevance
PROJECT NARRATIVE The development of new synthetic methods in organic chemistry is critical to enabling the continued discovery and production of pharmaceuticals and other chemicals that directly benefit society and public health. This proposal aims to develop a series of novel methods for C–C, C–N, and C–S bond formation that will allow for the rapid preparation of medicinally-relevant scaffolds across a variety of disease states. The newly developed reagents, and their associated reactions and applications, will be of immediate utility to synthetic chemists and chemical biologists in both academic and industrial laboratories.